Administrative Data Transfer Masking, Access, and Ethics Core

ABSTRACT: Administrative Data Transfer, Masking, Access, and Ethics Core
The National Dementia Workforce Study (NDWS) will be launched by a national team of experts in clinical care
of persons living with dementia, survey research, and health workforce research. The goal of the NDWS data
infrastructure is to allow researchers and policymakers to ask and answer scientific questions to help build the
workforce of clinicians and other professional care providers required by the growing population of persons
living with dementia in the U.S. The Administrative Data Transfer, Masking, Access, and Ethics Core will
oversee linking of the NDWS survey data with other sources of administrative and secondary data in
combinations that can maximize scientific insights while still preserving respondent and facility privacy.
Specifically, the Administrative Data Transfer, Masking, Access, and Ethics Core will: 1) Use Medicare,
Medicaid, and assessment data to derive process and quality outcomes to characterize care delivery to PLWD
for the clinicians, facilities, and agencies in each survey of the NDWS; 2) Prepare administrative and other
secondary information sources in data sets that can be linked with NDWS respondent survey data to gain
further insights into factors that influence the workforce as well as PLWD care outcomes; 3) Establish
guidelines for restricted data access to safeguard respondent privacy.